Site-Specific Non-Mutans Streptococci Etiologies of Dental Caries

DESCRIPTION (provided by applicant): The microbial etiology of dental caries continues to be researched and debated. While S. mutans is recognized as a prominent cariogenic species, caries - even severe caries - have been observed in the absence of detectable levels of S. mutans. It has been postulated that certain strains among primary plaque- colonizing species of streptococci may represent an alternative etiology of dental decay. These strains have been designated low-pH, non-mutans-streptococci (non-MS) variants. They are significantly more acidogenic and aciduric than is typical for their species and rival the acid-related properties of . mutans. Data from a handful of cross-sectional studies supports the hypothesized role for the low-pH, non-MS in caries etiology. In this application we propose to further test the hypothesis that low-pH, non-MS strains have a potential role in caries etiology by taking advantage of an ongoing study, the Iowa Fluoride Study, that has collected and banked site-specific samples from the occlusal surfaces of second molars from subjects enrolled long-term within the study. In particular, we have samples from identical sites within subjects at ages 13 and 17. Some of these sites show incipient decay (white-spot lesions) at age 17 after being clinically sound at age 13. We propose to: 1) Isolate non-MS strains of primary colonizing streptococci from second molar occulsal samples, determine the diversity of genotypes present, and the diversity of acid-related phenotypes for those strains; and 2) Correlate the acid-related phenotypes with the site-specific caries experience of the subjects from whom they were isolated. The study design will allow longitudinal and cross-sectional data analyses that represent a unique approach to testing this important hypothesis. PUBLIC HEALTH RELEVANCE: This application proposes to investigate whether dental caries may be caused by the presence of unique low-pH variants of streptococcal species that commonly colonize teeth and contribute to plaque formation. We will isolate strains from site-specific samples collected at different ages and correlate the acid properties of those strains with the clinical status of the sites from which they were isolated.

Public health relevance
This application proposes to investigate whether dental caries may be caused by the presence of unique low-pH variants of streptococcal species that commonly colonize teeth and contribute to plaque formation. We will isolate strains from site-specific samples collected at different ages and correlate the acid properties of those strains with the clinical status of the sites from which they were isolated.